A genetically modified Plasmodium falciparum sporozoite vaccine attenuated at the late-liver stage

ABSTRACT
In 2020 malaria caused 241M clinical cases and 627,000 deaths, the greatest numbers of annual deaths since
2012. There were more deaths in Africa from malaria than from COVID-19. There is an urgent unmet medical
need for a malaria vaccine that prevents infection and disease in individuals and can be deployed in mass
vaccination programs for malaria elimination. The RTS,S malaria vaccine was shown in a pilot implementation
program in >900,000 African infants to significantly reduced hospital admissions for malaria by 21% and
severe malaria by 30%. In late 2021 it was recommended by WHO for immunization of 5-month-olds.
However, it did not significantly reduce cerebral malaria, severe malaria anemia, or overall mortality, or prevent
Plasmodium falciparum (Pf) infection. Of vaccines under development, only Sanaria’s PfSPZ vaccines have
the efficacy against Pf infection to be considered for prevention of Pf infection in individuals or geographically
focused Pf malaria elimination campaigns. Sanaria’s 1st generation vaccine, PfSPZ Vaccine, is composed of
radiation-attenuated Pf sporozoites (SPZ), which arrest early in the liver stage. Sanaria’s 2nd generation
vaccine is PfSPZ-CVac (Chemoprophylaxis Vaccine). In PfSPZ-CVac, the parasites replicate in the liver,
biologically amplifying the immunogen load by up to 50,000-fold and then are killed by an anti-malarial drug.
PfSPZ-CVac co-administered with chloroquine (CQ), gave 100% vaccine efficacy (VE) against heterologous
controlled human malaria infection (CHMI) 12 weeks after vaccination using 22% the dose of PfSPZ needed to
achieve 80% VE at 9-10 weeks against heterologous CHMI with PfSPZ Vaccine. PfSPZ-CVac (CQ) is
therefore more protective than PfSPZ Vaccine at ~1/5 the dose. However, transient symptoms of malaria can
occur after 1st dose of PfSPZ, and if CQ is not administered appropriately, parasite multiplication in the blood
could cause severe malaria. In our Phase I grant, to retain the enhanced potency of PfSPZ-CVac and eliminate
its drawbacks, we genetically altered Pf to be able to fully replicate, but arrest prior to entering the blood by
deleting first one and then a 2nd gene to produce PfSPZ-LARC2 Vaccine and produced a master cell bank
(MCB). This vaccine is now being manufactured in compliance with cGMPs to produce PfSPZ-LARC2 Vaccine
and will be assessed for safety and efficacy in a clinical trial in the 2nd half of 2022. In this Phase II grant, we
propose to 1) manufacture 2 lots of this late arresting, replication competent (LARC) vaccine (PfSPZ-LARC2),
which is based on an African Pf parasite, for assessment in expanded clinical trials, 2) manufacture a Thai
strain of Pf (NHP4026) containing Asian variant antigens for regulatory agency directed vaccine assessment,
and 3) produce a PfSPZ-LARC2 vaccine based on NHP4026 that can be combined with African LARC2 as a
pan-global vaccine if needed. The project is intended to produce a potent, cost effective PfSPZ vaccine that
protects against highly variant Pf parasites worldwide.

Public health relevance
PROJECT NARRATIVE The WHO estimates that in 2020, malaria caused 241M clinical episodes and 627,000 deaths. This was a significant increase compared to 2019. While Plasmodium falciparum (Pf) accounts for much of the severe disease and most of the deaths, P. vivax (Pv) represents the most widespread and numerous malaria parasite with a range stretching even into temperate zones. Pv comprise the greatest proportion of infections and cases in some parts of the world; for example, in the Americas 68.3% (446,000) of 653,000 cases were attributable to Pv malaria in 2019. Evidence is accumulating to show that young children and pregnant women are particularly vulnerable to adverse clinical impacts of Pv malaria, including severe presentations, and preventing infections and relapse in these groups is a priority. Pv is responsible for at least 30% of malaria in U.S. travelers [5]. Efforts to prevent and control Pv malaria are impeded by emergence of drug resistant strains and by repeated relapses from dormant liver stage parasites called hypnozoites. A powerful tool is needed for eliminating Pf and Pv malaria from defined geographical areas, ideally a highly effective, long-acting yet low-cost vaccine that prevents infection, disease and parasite transmission. This proposal describes the development, characterization and assessments of a Plasmodium falciparum sporozoite (PfSPZ) vaccine that is late arresting replication competent (LARC) and has 2 genes Pfmei2 and PfLINUP deleted (PfSPZ-LARC2) and in addition a major immunogenic Pv protein the circumsporozoite protein (CSP). We describe the development of a Pf LARC parasite strain that expresses the P. vivax circumsporozoite protein (PvCSP). This parasite strain called PfLARC2-PvCSP is genetically attenuated to arrest development in the late liver stage, and will provide the basis for a bi-valent LARC PfSPZ Vaccine.